AZT IN TREATMENT OF PATIENTS WITH LYMPHADENOPATHY AND EARLY ARC

Study to evaluate the long term safety, tolerance, and efficacy of Zidovudine to treat subjects with symptomatic HIV infection, as manifested by early AIDS-Related Complex (ARC).